Pharmacogenetic discovery in the GRADE comparative effectiveness type 2 diabetes clinical trial

Type 2 diabetes has a heterogeneous pathophysiology, and is treated with various
glucose-lowering medications from classes that differ in their mechanisms of action.
Variability in treatment efficacy may be due to genetic variation, but data are needed to
guide specific pharmacotherapy addressing the pathogenic mechanisms affecting an
individual patient. The Glycemia Reduction Approaches in Diabetes: A Comparative
Effectiveness (GRADE) Study is evaluating the effectiveness of each of the four most
commonly employed glucose-lowering medications (sulfonylurea, GLP-1 receptor
agonist, DPP-4 inhibitor, basal insulin) added to a background of metformin. Among
5,047 randomized participants, 4,730 have consented to genetic analyses. We propose
to use a genome-wide association approach to test 1) whether specific genomic regions
or polygenic scores associate with the glycemic response to each of the four drugs, or to
a specific mode of action; 2) whether specific genomic regions or polygenic scores
associate with key intermediate traits of glucose homeostasis (e.g. insulin sensitivity, β-
cell function), or the occurrence of side effects and diabetes complications; 3) in a
subset of 1,600 participants with available DNA who have undergone continuous
glucose monitoring, whether specific genomic regions or polygenic scores associate with
the mismatch between glycated hemoglobin and average glycemia, or with glycemic
variability while on each drug; and 4) whether variants known to be associated with type
2 diabetes or related traits, polygenic scores constructed from such variants, or
physiology-driven partitioned genetic scores, are associated with response to each of
the four agents employed in GRADE. This proposal represents a full pharmacogenetic
exploration in the GRADE clinical trial designed to advance precision medicine in type 2
diabetes.

Public health relevance
Type 2 diabetes can be treated with various glucose-lowering medications, but guidance to match each drug to the pathophysiology affecting an individual patient is lacking. We plan to leverage the DNA samples and data of consented 4,730 participants in the Glycemia Reduction Approaches in Diabetes: A Comparative Effectiveness (GRADE) Study to conduct a genome-wide association study, in which we will identify genetic determinants of drug response, of glycemic traits relevant to specific modes of action, of side effects, and of diabetic complications. This pharmacogenomic resource will also enable the testing of polygenic scores constructed from established genetic variants for association with drug response endpoints, as a way to advance precision medicine in diabetes.